Immunosuppression-free transplantation through placental mimicry

Project Summary/Abstract
The ultimate goal in clinical transplantation is robust and specific host immunological tolerance toward
transplanted allogeneic tissue and cells. While systemic immunosuppression regimens have saved lives by
enabling long-term allogeneic graft survival, they come with a host of potentially severe side effects, including
infections and malignancies. The development of a method to induce donor-specific, localized tolerance toward
allogeneic grafts, and thereby eliminate the need for chronic systemic immunosuppression, would dramatically
reduce the risks associated with cell and tissue transplantation.
Typical tolerogenic immunomodulatory approaches are systemic, potentially resulting in off-target and
detrimental effects. Many groups have turned toward local delivery or presentation of immunomodulatory factors,
which can eliminate systemic and off-target effects, but have limited opportunity for renewal when exhausted,
resulting in a transient treatment. One approach to achieve more persistent localized immunomodulation
includes the use of tolerogenic cells, such as T regulatory cells, tolerized mesenchymal stem cells or tolerized
antigen presenting cells. However, while these cells can be influenced to take on a tolerogenic phenotype in
vitro, it is unclear whether, or for how long, these manipulated cells maintain this phenotype in vivo. An alternative
strategy would be the use of professional tolerogenic cells, such as placenta-derived trophoblasts, wherein their
primary physiological role is sustained and persistent maintenance of tolerance toward allogeneic tissue.
Our research approaches immunological tolerance from the perspective of the only physiologically natural
scenario of allogeneic tissue tolerance, placental pregnancy. In placental pregnancy, semi-allogeneic and fully
allogeneic conceptus are protected from immune response by the placenta, a fetus-derived organ consisting of
various types of trophoblasts which physically isolate the fetus from the mother. We aim to probe and exploit the
tolerogenic immunomodulatory mechanisms of trophoblasts and their capacity to induce tolerance in allogeneic
graft transplantation through three main projects: (1) develop artificial placenta organoids using tunable hydrogel
matrices to direct trophoblast differentiation and explore their immunomodulatory mechanisms in vitro; (2)
engineer a safe and translatable method of artificial placenta organoid transplantation for tolerogenic cell therapy;
(3) develop a tolerance-inducing vaccine via implantation of artificial placenta organoids for antigen-specific
tolerance against allogeneic grafts. The use of placenta-based mechanisms to induce tolerance toward
allogeneic grafts is a drastically understudied area of immunology, and presents an opportunity to widen and
enrich the broader research areas of transplantation and transplantation immunology.

Public health relevance
Project Narrative The proposed research is relevant to public health because it aims to develop a method to transplant cells and tissue in the absence of chronic systemic immunosuppression, which could lead to improved outcomes in the general population of transplant recipients. This project is relevant to NIH’s mission, as the development of methods to transplant cells and tissue in the absence of immunosuppression would impact tens of thousands of transplant recipients per year.